IGF::OT::IGF - GTRP AAV LAB SERVICES FOR NEI via NHLBI

To generate clinical grade material that is in compliance in accordance with Good Manufacturing Practices (GMP) and applicable State and Federal regulations, for use by NIH-funded investigators for clinical trial testing.